Metal mixtures, epigenome, adiposity and cardiometabolic risk across early life

ABSTRACT/PROJECT SUMMARY
In this project, we will examine prospective associations of blood metal mixtures mineral and DNA methylation
(DNAm) from the prenatal period to early childhood with adiposity and cardiometabolic risk across childhood and
adolescence.
We will leverage extant resources from four prospective cohorts: the TIGER Kids in Louisiana (N=342); the
EPOCH (N=350) and Healthy Start (N=350) in Colorado; and the Generation R Study (N=500) in the
Netherlands. The proposed study will include 1,542 children who are similar in age (4-16 years old) (discovery
n=1042: TIGER Kids, EPOCH and Healthy Start; replication n=500: Generation R Study). Key elements of this
proposal include directly-measured adiposity using gold standard methods (MRI and DXA), complementary
information on a suite of cardiometabolic measures (fasting glucose, insulin, and lipids), and rich covariate data
on lifestyle behaviors and Tanner staging. Additionally, the proposed study will generate new data on biomarkers
of early-life exposure to blood metals (arsenic, lead, mercury, cadmium, selenium, magnesium, iron, and zinc)
and DNAm at multiple time-points from birth through childhood for all four existing cohorts. In Aim 1, we will
examine prospective associations of blood metal mixtures from the prenatal period to early childhood with
adiposity and cardiometabolic risk across childhood and adolescence. In Aim 2, we will discover and validate
prospective DNAm patterns at birth and in early childhood that mark the relationship of prior metal exposure with
adiposity and cardiometabolic risk across childhood and adolescence. In Exploratory Aim 3, we will test whether
potentially modifiable lifestyle behaviors (infant feeding mode, diet quality, consumption of specific
foods/nutrients, activity level) mitigate the adverse effects of early-life metal exposure on adiposity and
cardiometabolic risk. If successful, our findings will inform future research on policies and programs (e.g.,
systems-level changes to nutrition guidelines) to mitigate exposure to toxic metal mixtures and enhance intake
of nutritious metals.

Public health relevance
Project Narrative In this project, we will examine prospective associations of blood metal mixtures and DNA methylation from the prenatal period to early childhood with adiposity and cardiometabolic risk across childhood and adolescence. If successful, our findings will inform future research on systems-level approaches to mitigate exposure to toxic metal mixtures as a way to stem the rising tides of obesity.